Core E: Outreach, Recruitment, and Engagement Core

ABSTRACT – CORE E: OUTREACH, RECRUITMENT, AND ENGAGEMENT CORE
The Outreach, Recruitment, and Engagement Core (OREC) will serve as a liaison between the Michigan
Alzheimer’s Disease Research Center and key stakeholders including patients, families, research participants,
and a variety of professional and lay community groups. To support ADRC goals of advancing research and
practice in Alzheimer’s disease and related dementias, the OREC leads the development, implementation and
evaluation of innovative means of health education and community outreach activities, with an overarching
goal of enhancing research study recruitment and retention. These efforts will be closely coordinated with the
activities of the Administrative, Clinical, Data Management and Statistical, Neuropathology, Biomarker, and
Neuroimaging Cores, and the Research Education Component; they will also involve key regional academic
collaborators at the University of Michigan (U-M), Wayne State University (WSU), and Michigan State
University (MSU), as well as ORE Cores within the national ADRC network. Community partnerships across
the state of Michigan and Northern Ohio (e.g., with the Michigan chapter of the Alzheimer’s Association and
the Michigan Dementia Coalition) will enhance the reach and depth of OREC programs. Core aims will address
the following: 1) education of key stakeholder groups about Alzheimer’s disease and related dementias and
available ADRC resources; 2) recruitment of a diverse population of research participants through strategic
outreach and engagement efforts, with emphasis on continuing to engage the Black American community in
southeastern Michigan, facilitated by a community-based participatory research (CBPR) approach developed
with input from our Detroit Advisory Council; 3) enhancement of efforts to retain research participants in
Center-sponsored studies, including its longitudinal cohort (LC) study the University of Michigan – Memory and
Aging Project; 4) development and evaluation of a protocol for disclosing individual research results with
clinical significance to participants in the LC; and 5) Contribution to Center efforts in professional training and
education, with a focus on dementia researchers and healthcare professionals. In carrying out its mission, the
OREC will draw upon the skills and experience of an interdisciplinary team with considerable expertise in
dementia care and support, health communication, caregiver and patient wellness, patient and provider
education and training, program evaluation, and community engagement. These activities will not only address
local and regional needs, but will also contribute to a national effort to promote Alzheimer’s disease research
and education.